The Alzheimer's Disease Tau Platform Clinical Trial

PROJECT SUMMARY / ABSTRACT
Tau protein is an attractive AD therapeutic target because the amount and anatomical distribution of insoluble
tau at autopsy is strongly correlated with the symptoms and severity of disease during life. Multiple tau therapies
are now in clinical trials for AD, with many new agents entering the clinic. New approaches to accelerating their
clinical development are urgently needed. A variety of AD biomarkers now exist, including CSF and plasma beta
amyloid ratios and phosphorylated tau (P-tau) levels, and amyloid and tau PET tracers, providing tools to
measure pharmacodynamic effects of amyloid and tau therapies on the core biology of AD. The goal of the
Alzheimer’s Tau Platform (ATP) trial is to conduct a randomized, placebo controlled, Phase 2 platform trial in
preclinical-prodromal AD that will simultaneously test at least two different tau-directed therapies, alone or in
combination with an anti-amyloid therapy, to determine safety, tolerability, and biological based proof of concept
based on the tau PET tracer 18F MK6240 and other tau biomarkers. Platform trials create efficiencies through
generation of a common clinical trial protocol and shared placebo groups to allow a greater number of therapies
to be tested in less time with less expense than by conducting multiple independent trials. This trial will test 5
therapeutic hypotheses involving combinations of 3 drugs versus placebo: Two tau therapies will be studied in a
2 x 3 factorial design (placebo vs. anti-amyloid [n=2] x two tau therapies or placebo [n=3]) for 24 months, in six
parallel arms. The key inclusion criteria for ATP will be >20 centiloids of amyloid PET uptake, 18F MK6240
temporal ROI SUVr >1.25, with a global Clinical Dementia Rating (CDR) of 0 or 0.5 and MMSE >23. Using these
criteria, we estimate that 150 participants per arm will be necessary to have 80% power to detect a 30% slowing
in the accumulation 18F MK6240 signal over 24 months of blinded therapy. Key secondary endpoints will be
changes in plasma P-tau species (-217, etc.) and neurofilament light chain (NfL), clinical rating scales and
volumetric MRI. Leveraging the experience and resources of the NIH AD Clinical Trial Consortium (ACTC), we
propose to enroll 900 participants at ~100 ACTC sites over 24 months, randomize them 5:1 drug:placebo for 24
months of blinded treatment, followed by a 24 month open label extension. We aim to: 1) test the ability of two
tau-directed therapies, either alone or in combination with an anti-amyloid therapy, to slow the accumulation of
tau PET signal over 24 months as compared to placebo or anti-amyloid therapy alone; 2) test the safety and
tolerability of 24 months of blinded therapy followed by an optional 24 month open label extension of combination
tau/anti-amyloid therapy; and 3) explore the ability of each of two tau directed therapies to slow disease
progression as measured by CSF and plasma biomarkers (plasma P-tau, NfL), volumetric MRI and clinical
assessments (Preclinical Alzheimer’s Composite [PACC], etc.). If successful, the ATP will provide data for
decision-making about which tau therapies or combinations to pursue in larger efficacy studies, an ongoing
resource to test new therapeutic approaches beyond tau, and will improve understanding of AD biology.

Public health relevance
PROJECT NARRATIVE The build-up of tau protein in the brain closely tracks with symptoms of Alzheimer’s Disease (AD) and can be measured with specialized Positron Emission Tomography (PET) brain scans and blood tests; new treatments that reduce tau are predicted to produce greater clinical benefits than currently approved AD drugs. This study will test the ability of two tau therapies to reduce brain tau levels either alone or in combination with a drug that reduces amyloid protein in patients with very early AD. Using an efficient clinical trial design adapted from cancer research, the study will identify whether either tau therapy by itself or in combination with an anti-amyloid drug is promising enough to be tested in future large studies to determine meaningful clinical benefit, as well as whether blood tests for tau could reduce the need for expensive PET scans in future clinical trials.